Training Program in Respiratory Neurobiology & Sleep

ABSTRACT
There is growing evidence of the role of sleep and circadian disorders in cardiovascular disease,
metabolic disorders, neurodegeneration and cancer. This reflects that sleep and circadian disorders have
systemic effects affecting multiple organs. While there is a growing and rapidly developing view as to the major
public health significance of sleep and circadian disorders, there is a paucity of investigators in the area,
particularly those employing state of the art approaches. This postdoctoral fellowship research training
program is addressing this issue. The program is housed at the University of Pennsylvania (Penn). It is part of
the comprehensive effort in research training by the Center for Sleep and Circadian Neurobiology at this
institution. Penn was the first institution in the United States to develop in 1991 a comprehensive medical
school-wide center for this activity recognizing the very multidisciplinary nature of sleep and circadian research
field. Since 1991 Penn has played, and continues to play, the leading role in research training in this field.
Penn has the most faculty investigators in the area of any institution nationally and the most research support.
While the research training program is well established, it continues to evolve to meet changing scientific
direction and needs. The program is now organized into 4 specific tracks: a) basic research; b) clinical and
translational research; c) behavioral science and “basic human research”; and d) implementation and
comparative effectiveness research. The program takes advantage of the infrastructure that has been
developed at Penn for research training. This includes the Office of Biomedical Postdoctoral Programs (BPP),
the Masters of Science in Clinical Epidemiology, the Masters of Science in Translational Research, and the
Masters of Science in Health Care Policy Research.

Public health relevance
LAY NARRATIVE There is growing evidence that sleep and circadian disorders have major public health significance. There is, however, a paucity of investigators in this area that this training program addresses. It supports training of individuals after their graduate degrees (MD, PhD and/or MD/PhD) in basic research, clinical and translational research, behavioral research and in implementation research.